Project 3 - Innate immunity and the HSV lytic/latent balance

Herpesviruses are a major source of morbidity and mortality in humans and their success is due to their ability
to establish latent infections, and to modulate the immunity of their hosts. These abilities render the virus
refractory to cure by chemotherapeutic agents, and to clearance by the immune system. While latency and
immunity to herpesviruses have been intensely studied, the mechanisms that control establishment,
maintenance and reactivation of latency remain obscure, especially for herpes simplex virus (HSV). This is due,
in part, to the high complexities of in vivo (mostly mouse) models that while highly informative, fail to inform
precisely about the unique relationship between HSV and the neuron, its target cell for latency. Recently, our
understanding of latency has been significantly enhanced by the development of physiologically relevant in
vitro systems employing primary cultured neurons that can be used in combination with more traditional in vivo
systems to interrogate the molecular basis of latency and immunity. The over-arching approach of Project 3 is
to use and develop relevant in vitro and in vivo models systems to demonstrate roles for intrinsic, innate, and
adaptive immunity and viral countermeasures that determine the balance of the latency/reactivation axis. Aim
1, with Projects 1 and 2, examines the structure and function of autophagosomes clusters (intrinsic immunity)
that are induced in sensory neurons during the establishment and maintenance of latency. We will probe these
newly-discovered structures with high resolution microscopy, and characterize gene expression and chromatin
patterns of HSV in cluster-positive neurons. Aim 2 examines the role of viral modulation of reactive oxygen
species and mitochondrial movement in cultured neurons on the ability of HSV to establish, and reactivate from
latency, and on the genesis of the interferon-dependent innate immune response. With Projects 1 and 2, this
aim will also examine the roles of HSV proteins ICP0 and ICP34.5 in the modulation of these responses and
their effects on gene expression and chromatin patterns. Aim 3 addresses the hypothesis that antibodies are
key immune determinants of HSV-1 replication, pathogenesis, and latency in the nervous system. The
activities of antibodies within sensory ganglia will be defined, and their roles in the control of replication, latency,
and reactivation, including effects on gene expression and chromatin, will be determined. With Project 1, the
ability of an experimental vaccine and antibodies to protect mice not only from mortality following HSV
challenge, but also from the long-lived behavioral pathology associated with neonatal infection will be
assessed. The general approach then is to continue collaborations with Projects 1 and 2, and, using Core B, to
develop and exploit our primary neuron and neonatal infection model systems interfaced with analyses with
Core A of gene expression and chromatin patterns, and experimental immunization. These approaches will
determine how different branches of immunity control latency, and how HSV counters these responses. This
framework will identify novel pathways to help intervene in the lifecycle of this persistent human pathogen.